Ferroportin and APP: Regulation of Iron Trafficking at the Blood-Brain Barrier

Redox active first row transition metals such as iron and copper have been implicated in the pathophysiology of amyliodogenic diseases; these correlations are poorly understood at the level of mechanism. We also have limited understanding of the physiologic role for which the amyloid precursor protein (APP) has been selected. However, the fact that the APP transcript contains an iron response binding protein (IRBP) stem-loop structure and like ferritin, APP protein synthesis directly correlates with cell iron content indicating that APP is part of the “iron regulon.” This iron regulation of APP remains an unknown with respect to both iron metabolism and amyloidogenesis; here we propose to test a specific premise with respect to a physiologic function of APP and its secretase-dependent products. First, published work from our lab provides a clue as to the connection between APP and iron metabolism. We have identified a unique function exhibited by a 22-amino acid residue peptide element at the N-terminus of the BC helical bundle contained in the E2 domain in APP. Using recombinant ?B?C or a synthetic peptide (residues 327-348 within ?B?C), we show that this sequence tethers APP to and stabilizes ferroportin (Fpn) in the plasma membrane. Fpn is the sole mammalian iron exporter; by stabilizing Fpn in the PM, sAPP stimulates cell iron-efflux. We have designated this species FTP for Ferroportin Targeting Peptide. In binding to Fpn, sAPP/FTP acts as antagonist of the key regulator of Fpn function, hepcidin (Hepc) indicating that sAPP is a key regulator of iron efflux from any mammalian cell that expresses this amyliodogenic protein or shares an interstitial space that includes another cell type that does. Although the effect of sAPP on Fpn plasma membrane display is now established, the molecular basis of this activity and its physiologic function remain significant unknowns, significant because of: 1) the key role APP and its products play in Alzheimer's disease and in cerebral amyloid angiopathy, CAA; 2) the implied role that iron plays in this neurodegenerative disorder; and 3) the potential that FTP or its synthetic congeners may have as (a) pharmacologic regulator of iron metabolism. The key element of this Application is our blood-brain barrier transwell model system composed of brain capillary endothelial cells, astrocytes and neurons, i.e, the cells of the neurovascular unit. Our premise is that: 1) iron regulates the expression of APP so as to modulate the level of iron in the brain's abluminal space; 2) iron also modulates the processing of APP to Aß; and 3) Aß in turn serves as an iron scavenger and by this mechanism is cytoprotective. We will test this premise by a combination of biophysical structure-function, cell biologic and genetic approaches including the use of primary cells cultured from strategically chosen mice KO lines. This research plan will: 1) provide novel insight into the mechanism of the Fpn/APP interaction and its role in cellular trafficking of iron; 2) test our premise that mismanagement of this iron leads to increased permeability in our BBB model; and 3) test our premise that Aß is a key player in preventing this capillary leakage by suppressing iron's activity as a potent pro-oxidant.

Public health relevance
Project Narrative There is abundant clinical data that suggests a link between amyloidogenesis and iron metabolism in the central nervous system. We have established one basis of this link: the amyloid precursor protein (APP) interacts with the sole human iron efflux protein and stimulates iron efflux from the cells in the CNS. The objective of this research plan is to develop strategies designed to reveal the mechanism of this regulation of iron efflux by APP thus providing mechanistic understanding of how iron trafficking and amyloid deposition are linked and thereby contribute together to the progression of neurodegenerative disease.